Reproducible and Accurate PD-L1 Immunohistochemistry Biomarker Quantification Using Virtual Multiplex Immunofluorescence Restaining

Project Summary
Groundbreaking immunotherapy (IO) drugs offer durable response and improved survival in cancer patients who
previously had limited treatment options. The semi-quantitative assessment of PD-L1 protein expression on
tumor and/or immune cells (lymphocytes, macrophage) by a certified pathologist (“positive”, “negative”, “low”,
“medium”, “high”) is the most prevalent biomarker for guiding clinical decision-making in IO. However, PD-L1
expression is difficult to score on standard immunohistochemistry (IHC) slides. The disagreement among
pathologists for immune cell PD-L1 scoring is greater than 50%, which can lead to a high percentage of patients
receiving IO when they are unlikely to benefit. This discordance could explain why most cancer patients do not
benefit from these groundbreaking yet expensive Ios (costs > $200K / year per patient). Thus, there is an urgent
unmet clinical need to identify patients who will not benefit from IO. As opposed to standard single-plex IHC,
multiplex immunofluorescence (mpIF) staining, though expensive, provides the opportunity to examine panels
of several markers (including tumor- and immune-specific markers) individually or simultaneously as a composite
while permitting stain standardization, objective scoring, and cut-offs for all the markers; mpIF also has higher
sensitivity and diagnostic prediction accuracy than IHC PD-L1 scoring. This opens up unique opportunities to
leverage mpIF-stained images (with objective ground truth tumor/immune cell annotations and absolute PD-L1
intensities) coupled with recent deep learning methods to improve the explainability and interpretability of the
conventional IHCs broadly. In previous work, restained and co-registered IHC/mpIF whole-slide images (WSIs)
were used to create a deep learning virtual mpIF restaining algorithm, DeepLIIF (Deep Learning Inferred IF), for
scoring IHC Ki67 and other nuclear markers. DeepLIIF is the only IHC scoring globally available as a public/free
cloud-native platform with a user-friendly web interface and AI-ready IHC/mpIF datasets; it has been extensively
validated in low- and high-resource settings. Recently, DeepLIIF was extended for more reproducible and
accurate visual IHC PD-L1 scoring in tumor cells for lung cancer. The work proposed under this NIH R01 will
further improve DeepLIIF PD-L1 scoring by incorporating mpIF immune cell (lymphocytes and macrophage)
markers, whole-cell (rather than simple nuclear) segmentation, and large/diverse datasets across lung and
bladder cancers. Additionally, the team will (1) validate DeepLIIF PD-L1 tumor and immune cell scoring on
thousands of IHC PD-L1 whole-slide images (with manual readouts and ground truth IHC/mpIF for a subset)
spanning different antibodies, platforms, and scoring systems, and (2) validate DeepLIIF-derived spatial
biomarkers and PD-L1 scores on lung and bladder cancer datasets with clinical outcomes. Successful validation
will establish DeepLIIF as an interpretable, tissue non-destructive, and cost-efficient solution to accurate IO
patient stratification.

Public health relevance
Project Narrative The PD-L1 protein assessment by a pathologist is critical for guiding clinical decision-making in groundbreaking cancer immunotherapies as well as some standard chemotherapies. However, PD-L1 is difficult to quantify on standard immunohistochemistry-stained slides scored by pathologists, often requiring specific training for each tumor type. Using more informative multiplex immunofluorescence staining as a reference standard, we propose to refine, optimize, and validate an innovative computational tool to standardize and quantify PD-L1 on standard immunohistochemistry staining for widespread clinical use.